Integration of Hypertension Management into HIV Care in Nigeria: A Task Strengthening Strategy - Resubmission - 1 - Revision - 3 - Supplement

PROJECT SUMMARY/ABSTRACT
This application is a request for an Undergraduate Research (diversity) Supplement for Mr. Adrian Duah. The
supplement aims to provide mentorship, training, and advance research experience for an undergraduate
student via the Integration of Hypertension Management in HIV Care in Nigeria: A Task Strengthening Strategy
grant (#HL147811). Within the scope of Dr. Ogedegbe’s R01 (1R01HL147811-01A1), Mr. Duah’s undergraduate
research plan will be to assist with various technical aspects for the parent study. He will focus on assessing
hypertension management processes within study sites or the primary healthcare centers (PHCs) in Lagos by
conducting data collection and analysis of the adoption, sustainability and mediators of the task strengthening
and practice facilitation strategies – all of which are key components for the parent study’s implementation and
sustainability. Through this project, Mr. Duah will receive assistance with career development opportunities to
strengthen his application to medical school.

Public health relevance
PROJECT NARRATIVE This Undergraduate Research (diversity) Supplement request for Mr. Duah aims to provide mentorship, training, and research experience via the Integration of Hypertension Management in HIV Care in Nigeria: A Task Strengthening Strategy grant (#HL147811). The research portion of this supplement will focus on assessing hypertension management processes within the study sites or the primary healthcare centers (PHCs) in Lagos by collecting and analyzing survey data from fidelity and mediator assessment instruments on Practice Facilitators and health facility. The proposed Research Experience Plan will enhance and expand Mr. Duah’s research skills and knowledge in conducting hypertension-focused implementation studies, strengthen his application to medical school, and ultimately prepare him to become a physician-scientist with a practice and research focus on health disparities within African-American communities.